Research Training Program in Disease-Oriented Neuroscience (R25)

SUMMARY
This Research Training Program in Disease Oriented Neuroscience is designed to facilitate the transition
between graduate training and a research-based career in neurology and neurosurgery. R25 program trainees
receive career mentoring from experienced clinician scientists in Neurology and Neurosurgery along with
research mentoring from leading clinical neuroscience laboratory research faculty drawn from multiple
departments and schools within the University of Pennsylvania. A focused educational program supplements
laboratory research and includes training in translational research methods, applications, and the responsible
conduct of research. The program is conducted in a large research-oriented institution with leading residency
programs in adult and child neurology and in neurosurgery that trains some of the best candidates in the
country and has an outstanding track record of fostering research oriented careers and trainee diversity. Over
the past program period, 6 of the 7 graduating R25 trainees have received K awards. The R25 pathway has
been further integrated into the residency training program at all phases including residency application review,
applicant visit and interview procedures, advance mentorship and research opportunities for matriculated
applicants, intensive support for the selection of mentors and the development of an R25 supplement request,
and multiple levels of clinician scientist career development support. Between the neurology and neurosurgery
residencies, there are over 200 faculty members in our departments, ranging from master clinicians, clinical
educators, and clinical investigators to physician/scientists and basic scientists. 80% of graduating residents
over the past 15 years have remained in academic medicine, and many have chosen careers as clinician
scientists. The Hospital of the University of Pennsylvania and Children's Hospital of Philadelphia at the
Perelman School of Medicine, where most of the clinical residency and fellowship training occurs, are located
within a highly compact university campus in West Philadelphia spanning a radius of less than one half mile.
Penn is also home to the first neuroscience institute in the country, the Mahoney Institute for Neurosciences,
which consolidates almost 200 faculty members from 32 departments and six schools engaged in
neuroscience research at Penn. The range of research opportunities for our R25 trainees can thus be
extended to the wider neuroscience community inside and outside of our clinical departments through co-
mentorship of trainees with a diverse array of eminent scientists carrying out research relevant to the NINDS
mission to reduce the burden of neurological disease.

Public health relevance
NARRATIVE The fields of neurology and neurosurgery are poised to make rapid advances in the treatment of neurological disorders, but the success of this endeavor depends on the availability of a cadre of academically based clinician scientists who are engaged in translational research, and who will catalyze the translation of advances between the laboratory and the bedside. The proposed program has been refined over three project periods and provides a facilitated and intensively mentored pathway to a research career as a physician-scientist in the clinical neurosciences.